Identifying Molecular Markers and Local Axonal Projections of Novel Neuron Types in the Auditory Midbrain

Project Summary/Abstract
In the inferior colliculus (IC), the midbrain hub of the auditory pathway, most neurons have local axon collaterals,
suggesting that the IC contains complex local circuits that support critical auditory computations. To understand
how local circuits in the IC support auditory computations, it is essential to determine the wiring diagram by which
specific types of IC neurons interconnect. However, it has proven difficult to reliably identify IC neuron types and
map the local axonal connections using conventional approaches. Recently, molecular markers for four IC
neuron types have been identified by screening transgenic mouse lines, but the identity of most IC neuron types
remains unknown. By leveraging Next Generation Sequencing data from the Allen Brain Cell Atlas, we have
identified two new candidate molecular markers for IC neuron types: secreted phosphoprotein 1 (SPP1) and
prodynorphin (PDYN). Our preliminary in situ hybridization results show that Spp1 and Pdyn label two separate
populations of excitatory neurons distinct from those previously identified in the IC. Based on our preliminary
results we hypothesize that SPP1 and PDYN are markers of IC neuron types characterized by internally
consistent morphological, physiological, and anatomical features, and exhibiting stereotyped patterns of local
axonal projections. To test this hypothesis, in Aim 1 we will use molecular, anatomical and electrophysiological
approaches to identify the distribution, morphology and physiology of SPP1 and PDYN neurons. We expect Aim
1 will demonstrate that SPP1 and PDYN mark two previously unidentified IC neuron types. Previous studies
have shown that neurons in the central nucleus of the IC tend to form local axon projections that follow one of
three patterns: remain in the same isofrequency lamina as the soma, project to a specific isofrequency lamina
distal to the soma or spread across multiple isofrequency laminae. However, it is not known whether individual
IC neuron types exhibit homogenous or heterogenous patterns of local projections and whether those local
projections preferentially synapse onto inhibitory or excitatory neurons. Based on precedents in other brain
regions, we hypothesize that SPP1 and PDYN neurons each have a strong tendency to follow one of the
aforementioned local axon projection patterns and to preferentially target a subset of IC neurons. We will test
this hypothesis in Aim 2 using two approaches. First, using sparse labeling, clearing and light sheet microscopy,
we will determine the axonal and dendritic morphology of SPP1 and PDYN neurons across the entirety of the
IC. Second, to determine postsynaptic target patterns, we will use expansion microscopy and immunolabeling
to map the distribution of SPP1 and PDYN synapses on inhibitory and excitatory postsynaptic densities. The
expected results from Aim 2 will allow us to generate hypotheses about the functional roles of SPP1 and PDYN
neurons in local IC circuits. Overall, our results will reveal the fundamental physiological and anatomical
properties of two IC neuron types and provide insight into how these neuron types contribute to local circuits
function in the IC.

Public health relevance
Project Narrative The ability to isolate and selectively manipulate neuronal subpopulations is critical for uncovering how those subpopulations contribute to circuit-based computations. The inferior colliculus (IC), a critical brain center for processing sound information, is made up of a diverse population of neurons that form a dense network of local circuits, but the identity of most IC neurons and the organization of local circuits in the IC remain largely unknown. The proposed research will identify the physiological and anatomical properties of two new subpopulations of IC neurons, SPP1 and PDYN, and determine how these neurons contribute to local circuits in the IC, providing insights into the fundamental mechanisms that underlie auditory computations in the IC.